MONTE CARLO MODELING OF DIFFUSE LIGHT TRANSPORT: TISSUE VOLUME COMPUTATION

Novel Monte Carlo techniques are being developed to quantitatively determine the tissue volume sampled by non-invasive diffuse imaging modalities. Novel features of these methods include the use of expected value estimators and the explicit consideration of the number and location of photon interactions within the turbid medium. The computation of tissue sampling volumes and its variation with tissue optical properties and instrument configuration parameters greatly aid in the design of novel probes customized for a particular application.